Nurse LEADS: Training in Nurse-LEd models of care ADdressing the Social Determinants of Health

ABSTRACT
Social Determinants of Health (SDOH), which are the conditions in which people are born, grow, live, and
age, contribute to up to 80% of population health and drive health inequities. Nurses, as the largest and most
trusted segment of the healthcare workforce, are uniquely positioned to lead national efforts addressing
SDOH. However, nurse scientists responsible for generating evidence for care models have not typically
received specialized research training in addressing SDOH. Additionally, a lack of diversity in the nursing
workforce limits the profession's ability to engage populations most affected by health inequities. Our
proposed training program, Nurse LEADS (Training in Nurse-LEd models of care ADdressing the Social
Determinants of Health), aims to offer innovative training to nurse scientists at the intersection of health
equity, SDOH, and nurse-led models of care. Trainees will develop skills in digital health, advanced analytics,
engagement science, and multisector partnership as essential methodological approaches and tools for
promoting health equity. Specifically, Nurse LEADS aims to: 1) recruit and retain pre- and postdoctoral
trainees (N=10) from groups underrepresented in nursing science (> 75% of trainees) for advanced research
training in health equity, SDOH, and nurse-led models of care; 2) support trainees in contributing to emerging
theoretical frameworks and methodological approaches for developing and scaling nurse-led models of care
addressing SDOH; 3) develop trainee methodological expertise in leveraging digital health and advanced
analytics for conducting cutting-edge research evaluating nurse-led models of care addressing SDOH; 4) and
apply engagement science and multisector partnerships in the development of nurse-led models of care
addressing SDOH. Duke University School of Nursing (DUSON) will partner with two minority-serving
institutions without research doctorate training programs in nursing, North Carolina Central University
(NCCU) and the University of Texas at El Paso (UTEP), to attract nurses from underrepresented
backgrounds. Trainees will be supported by mentoring teams that include mentors from underrepresented
backgrounds and experts addressing SDOH. Trainees will participate in career development activities,
monthly Nurse LEADS seminars, three courses involving experiential learning practicums, tailored learning
experiences drawing from seminars, workshops, and courses from participating departments at Duke, and
training in the responsible conduct of research. Additionally, postdoctoral trainees will be required to complete
pilot research contributing to a nurse-led model of care addressing SDOH and mentor predoctoral trainees.
This novel training will enhance the capacity of nurse scientists from diverse and underrepresented
backgrounds to promote health equity and create novel, evidence-based models of care addressing SDOH.

Public health relevance
RELEVANCE STATEMENT Addressing the social determinants of health is a key strategy to improve population health and address health inequities. This training program will provide nurses from diverse and underrepresented backgrounds with specialized research training in developing, testing, and scaling nurse-led models of care that address the social determinants of health.